Anatomic microniches and their contribution to vascular remodeling in pulmonary hypertension

Pulmonary hypertension (PH) is a poorly understood disease that causes pathologic remodeling of the
smaller diameter vessels of the lung, leading to progressive heart failure. This proposal will support the
critically needed studies to advance our currently limited understanding of the development of pulmonary
hypertension. Launching from her career development award findings, the PI (Lavannya Pandit, MD) outlines
a five-year plan to investigate the mechanism by which the K2P (two-pore domain) family of potassium ion
channels attributed to vascular smooth muscle cells participates in the vascular remodeling targeted to the
smaller diameter resistance-vessels of the lung, a defining pathologic characteristic of pulmonary hypertension.
This work will be performed at the Michael E. DeBakey Veterans Affairs medical center (MEDVAMC), which is
affiliated with Baylor College of Medicine in the Texas Medical Center, Houston. Important collaborative studies
will be performed within neighboring institutions at the Texas Medical Center (University of Texas Health
Science Center and University of Houston.) The project has been developed with consultative guidance from
renowned experts in the field of ion channel and pulmonary vascular cell biology who will continue their active
participation over the five-year duration of the proposed studies. Preliminary microarray data from explanted
human PH pulmonary arteries implicated a role for K2P channel dysfunction. We hypothesize that the K2P ion
channel dysfunction causes pathologic growth and constriction of smooth muscle cells specific to the smaller
diameter resistance vessels. The scientific approach utilizes primary pulmonary vascular smooth muscle cells
from both larger conduit and smaller resistance pulmonary vessels of both nonsmoking cadaveric controls and
explanted PH human lung tissues with parallel studies utilizing a mouse model of PH. We will test how
anatomic location determines specific K2P ion channels’ effect on the pulmonary vascular smooth cell
intracellular pathways for growth and contractility. The first objective of this proposal examines how anatomic
location within the pulmonary vascular bed affects K2P ion channel expression and function in vascular smooth
muscles. We will measure K2P channel expression, current density and resting membrane potential in
pulmonary vascular smooth muscle cells, attributing changes in K2P ion channel expression and function to
anatomic origin. The second objective of this proposal maps the interaction between the K2P channel and
endothelin-1(ETR) and thromboxaneA2 receptors (TXA2) by measuring intracellular ETR and TXA2 trafficking
using a radioligand assay and confocal microscopic imaging. These results link anatomic location of the K2P
channels to smooth muscle cell receptor ligand signaling (vasoconstrictors: endothelin-1 and thromboxaneA2)
that are currently implicated in PH. The third objective is to establish a functional role of K2P ion channels in
the cellular processes leading to PH vascular remodeling by experimental genetic and pharmacologic
modification and restoration. At the conclusion of these translational human tissue studies, we will delineate
the role of K2P ion channels in the development of PH vasculopathy.

Public health relevance
Pulmonary hypertension (PH) is caused by narrowing and contraction of the small blood vessels of the lung, leading to irreversible heart failure. PH most commonly occurs in patients with advanced heart and lung disease and is disproportionately more prevalent in veterans compared to other populations. As PH has no cure, we need to understand the causes of lung vessel narrowing and contraction to design better treatments for PH. This project will try to understand how the movement of potassium and calcium ions in and out of cells that line the lung blood vessels control how these blood vessel contract and relax, and how blood vessels become irregularly narrowed, inhibiting blood flow in the lungs. Understanding the factors that control potassium and calcium in these cells will promote the discovery of targeted new drugs to benefit patients suffering from PH.